Epigenetic modulations by sleep to mitigate neurodegeneration

Project Summary/Abstract
Sleep loss is frequently reported early in tauopathies, which are neurodegenerative diseases such as Alzheimer's
disease (AD), where abnormally hyperphosphorylated tau protein accumulates in the brain. Extensive evidence
suggests a reciprocal relationship between sleep-wake disruption and enhanced tau aggregation, with the
accumulation of tau aggregates further disrupting the sleep-wake cycle in both animal models and humans. How
sleep loss mechanistically contributes to neurodegeneration remains unknown, which is important as targeting
early sleep dysfunction could be the key to combating neurodegenerative diseases. My recent publication
demonstrated that subjecting healthy mice to sleep deprivation (SD) results in substantial inflammatory microglial
reactivity and metabolic impairments in the brain, similar to those observed in disease mouse models.
Furthermore, numerous publications from our lab have emphasized the importance of microglial reactivity in
influencing neuronal damage and brain atrophy using the P301S mouse model of tauopathy. This is exemplified
by the dramatic reduction in neuroinflammation and tau-mediated neurodegeneration in mice lacking expression
of triggering receptor expressed on myeloid cells type 2 (TREM2), a gene selectively expressed in microglia in
the brain. This led me to hypothesize that changes in sleep could epigenetically alter microglial responses to
intraneuronal tau aggregates, thereby directly influencing the progression to neurodegeneration. To address this
hypothesis, I used P301S mice lacking TREM2 or expressing the AD-associated R47H variant, or the common
variant as a genetic means to identify distinct microglial responses influenced by SD. My preliminary data showed
that chronic SD during early life followed by sleep recovery was neuroprotective and reduced TREM2-dependent
microglial reactivity. This finding raises the intriguing possibility that sleep architecture can be re-trained to
potentiate long-term transcriptional changes in microglia, reducing inflammatory damage and ultimately
promoting neuroprotection by acting as an ‘epigenetic memory’ that determine disease outcomes. I will test this
hypothesis in Aim 1. My pilot study also revealed that SD after onset of pathological tau overrides the
neuroprotective effects of lack of TREM2 in P301S mice, leading to increased microglial reactivity and brain
atrophy. This suggests that SD has the potential to exacerbate neuronal damage by epigenetically overriding
the homeostatic restrictions on persistent inflammatory cascades typically maintained by the absence of TREM2
signaling in microglia. I will address this hypothesis in Aim 2. These aims will investigate the mechanistic impact
of sleep on genetic regulatory processes within microglia, revealing its functional consequences in the context
of tau-mediated neurodegeneration. A K99/R00 Award will provide me the opportunity to be trained in chromatin
and methylation profiling as well as enhance my expertise in sleep and neurodegeneration research in the Wang
and Holtzman labs at Washington University. These experiences will build the foundation of my future
independent research in sleep and epigenetic mechanisms in neurodegenerative diseases.

Public health relevance
Project narrative Alzheimer’s disease and related neurodegenerative diseases represent a major public health challenge, with a great demand for exploring and targeting early disease hallmarks that can delay or prevent disease progression. Sleep dysfunction is a notable unifying early hallmark across various neurodegenerative diseases, prompting this proposal's investigation into how my observed neuroprotective effects of sleep influence epigenetic mechanisms to prevent chronic neuroinflammation and neurodegeneration. The experiments proposed to address this challenge will leverage cutting-edge molecular technologies to probe the epigenetic influence on inflammation triggered by sleep deprivation, which will improve our understanding of chromatin and methylation changes as a regulator of microglial cell fate across neurodegenerative diseases.